Decoupling reproductive and somatic aging using novel C. elegans technology

ABSTRACT
As women age, the risk of infertility and recurrent pregnancy loss rises; however, the molecular mechanisms
driving the onset and progression of reproductive senescence remain largely unexplored. A key challenge is that
reproductive aging is largely coupled with the decline of somatic health, complicating efforts to interrogate genes
and pathways that solely govern reproductive cessation. We propose that uncovering how the nutrient-sensing
mammalian target of rapamycin complex 2 (mTORC2) regulates reproduction could be crucial for decoupling
reproductive longevity from somatic aging. However, the role of mTORC2 in reproductive aging is poorly
understood. To pursue this research, we could study reproductive health decline in humans, primates, and mice;
however, such studies are often complex, expensive, and subject to high variability. Instead, the nematode C.
elegans is a powerful model system to study reproduction declines, as its reproductive cessation, like in humans,
is driven by a decline in oocyte quality during mid-adulthood. Another challenge is that, although worms are by
far the most accessible model for gaining mechanistic insights into reproductive senescence, manually tracking
the reproduction of hundreds of individual worms each day is highly labor-intensive. To address this, we aim to
design and develop an automated device to assay reproductive traits in C. elegans, allowing us to disentangle
the molecular underpinnings of reproductive aging from those of somatic aging. Our proposed research will focus
on SGK-1 kinase, a critical component of mTORC2, whose dysregulation in humans has been linked to
reproductive failure. We will investigate how autophagy, fat metabolism, and mitochondrial dynamics regulate
reproductive senescence downstream of SGK-1—independently of somatic aging. To accomplish these
objectives, we will utilize tools and techniques across diverse fields of microfluidics, machine learning, genetics,
and genomics. This interdisciplinary R15 project is ideally designed for undergraduate and junior graduate
students, providing them with hands-on experience in engineering, computer science, and biology while
emphasizing the importance of cross-disciplinary collaboration. Through this project, students will gain
experience in developing machine learning algorithms, building devices, and performing biological assays. In
doing so, they will be equipped to establish new paradigms for exploring the interplay of multiple molecular
pathways governing reproductive senescence.

Public health relevance
NARRATIVE Little is known about genes and pathways that regulate the onset and progression of reproductive senescence mainly because reproductive and somatic aging is largely coupled. C. elegans is an ideal model system to decouple the biology of reproductive and somatic health if we can engineer novel technologies that automate laborious manual worm assays. This is an ideal project for a training grant as the technology that automates worm assays is not complicated and biological experiments for this proposed research are standard experiments.